Knowledge-informed Deep Learning for Apnea Detection with Limited Annotations

PROJECT SUMMARY
Sleep apnea is a common chronic respiratory disease characterized by breathing difficulties during sleep.
Prevalent clinical practice to diagnose sleep apnea requires manual identification of apnea occurrences, which
is expensive and time-consuming. Recently, machine learning has attracted much attention to diagnose apnea
based on physiological signals collected via wearable devices. However, most existing studies rely on strongly
supervised learning for the detection, and fine-grained annotations are required to achieve a high level of
granularity. In practice, it is usually expensive and time-consuming to acquire a large dataset with temporally
fine-grained annotations (i.e., detecting apnea within short time epochs). Consequently, the limited availability of
fine-grained annotations hinders the wide implementation of machine learning and limits its granularity.
The ultimate goal of this research is to create a weakly-supervised machine learning framework that incorporates
annotations of different granularity levels and clinical domain knowledge for healthcare data analytics. In
particular, this study focuses on deep learning because it has shown superior performance and great potential
in aiding the analysis of clinical data. The technical objective of the proposed study is to create new deep learning
models that incorporate coarse-grained annotations and clinical knowledge for detecting apnea at a high level
of granularity based on multiple physiological signals. The specific aims of this proposal are as follows.
Aim 1. Systematically identify and quantify the apnea-related patterns in physiological signals. The
proposed study will numerically explore the physiological signals to elucidate the patterns related to apnea
and other sleep disorders based on feature engineering and statistical learning techniques.
Aim 2. Incorporate coarse-grained annotations and clinical knowledge into deep learning models for
apnea detection. We will establish new deep learning models to integrate incomplete fine-grained
annotations, coarse-grained annotations, and clinical knowledge for apnea detection.
Aim 3. Develop an algorithm to adaptively acquire annotations for performance improvement. To
further improve the performance of the deep learning model, we will develop an adaptive algorithm to
determine whether and where to acquire more annotations from physicians and the level of granularity.
The proposed study will address the challenge of generating fine-grained predictions given incomplete or no
fine-grained annotations in computer-aided apnea detection. The proposed model will be an advancement to
robust and interpretable deep learning that incorporates coarse-grained annotations and domain knowledge.
The expected results of study will provide important insights in addressing similar challenges in other biomedical
applications, enabling novel real-world solutions such as clinical decision-making support systems, in-home
apnea monitoring, and mobile health.

Public health relevance
Project narrative To achieve a high level of granularity, existing sleep apnea detection methods based on physiological signals usually require fine-grained annotations on the sleep status that are expensive and time-consuming to obtain. To address this issue, the proposed project aims to incorporate annotations of different granularity levels and clinical domain knowledge into a deep learning framework for sleep apnea detection. It can be extended to wide range of practical, patient-centered applications and support our ultimate research goal to establish an efficient and cost-effective weakly supervised learning framework for complex biomedical data analytics to support clinical decision-making.